Role of dimer formation in modulating neuronal sodium channel properties

Summary/Abstract
Voltage-gated sodium channels are major contributors to the generation and propagation of action potentials in
neurons and muscle. Changes in the properties of sodium currents can substantially alter the excitability of
excitable cells. Indeed, sodium channel variants have been associated with a wide array of disorders of
excitability, including pain, epilepsy, ataxias, autism, myotonias and arrythmias. A multitude of sodium channel
disease mutations have been characterized. Many mutations can alter diverse sodium current properties and
the observed changes can range from profound to subtle. Interestingly, although many mutations have dominant
effects, the vast majority of characterizations have focused on isolated channel variants. Several recent studies
suggest that some voltage-gated sodium channels can form dimers and that dimer formation may alter the impact
of specific variants on sodium current properties. If dimer formation substantially alters sodium current properties
and/or the physiological consequences of disease mutations, then investigations of the functional consequences
of disease mutants in the presence of wild-type channels, other variants and even other isoforms may be needed
to fully understand how specific channel isoforms and variants contribute to electrogenesis and different
pathological conditions. We will investigate if dimer formation can result in changes in multiple properties,
including activation, deactivation, fast inactivation, slow inactivation and persistent currents of Nav1.1 and
Nav1.7 isoforms. Next, we will use Proximity Ligation Assays to examine the potential of dimer formation on
brain isoforms in cell systems. Finally, we will examine potential consequences of dimer formation on Nav1.6
and Nav1.7 channel variants associated with pain expressed in dorsal root ganglion neurons to help determine
if dimers can impact the properties of channels in a natural cell background. This exploratory research project
targets several key gaps in our knowledge relating to the potential consequences of VGSC dimers. A fuller
understanding of this phenomena could lead to a more complete understanding of channelopathies and possibly
spur the development of novel treatment strategies.

Public health relevance
Project Narrative Voltage-gated sodium channel proteins are critical determinants of muscle and nerve cell electrical activity. Recent evidence suggests that these channels can be modified by the formation of protein dimers. This project investigates the role of dimer formation in modulating sodium channel activity and the impact of disease-associated mutations.